Defining the role of the TLO gene family in Candida albicans parasexual processes

PROJECT SUMMARY
In eukaryotes, cell states transitions often require major transcriptional shifts that are subsequently
reinforced through feedback loops that maintain stable expression of the newly acquired cellular phenotype.
Candida albicans, a diploid commensal yeast and significant opportunistic pathogen, has been found to adopt a
number of morphologically-distinct cell states that modulate its interaction with the human host. The phenotypic
switch between the white and opaque cell states governs entry into the parasexual mating system by opaque
cells and regulates the balance between virulence and commensalism in different host niches. Previous work
has shown that switching between these states is regulated, in part, by the Mediator complex, a major
transcriptional regulatory complex in eukaryotes. However, mutants within the Tail module subunits of Mediator
that are necessary for formation of the opaque state affect incorporation of other subunits into the complex. More
specifically, deletion of MED3 from the Tail module also causes the loss of Med2 from Mediator. In C. albicans,
MED2 is encoded by the telomere-associated (TLO) expanded gene family, which can function as
interchangeable Med2 subunits of Mediator. Thus, it is unclear if C. albicans phenotypic switching is affected by
inactivation of MED3 or TLO genes in Mediator. Individual TLO genes have diverse functions based on
overexpression studies with multiple genes often regulating a single trait. Therefore, we hypothesize that the
TLO gene family as a whole is necessary for the white-opaque switch and progression through the parasexual
cycle, with individual TLO paralogs possessing unique regulatory impacts on parasexual processes. Aim 1 will
test necessity of the TLO gene family on interconversion between the white and opaque cell states by utilizing a
recently built TLO-null strains in comparison to the med3/ and wild-type strains. Furthermore, we will evaluate
the phenotypic impact of complete TLO loss on the pheromone response and mating efficiency of opaque cells,
as MED3 mutants ectopically induced into the opaque state also suffered from reduced mating efficiency. To
determine if specific TLO paralogs are responsible for alterations in cell state transition and mating, Aim 2 will
produce a panel of strains containing a single epitope-tagged TLO paralog with their native promoters
reintroduced into the null background. These strains will be tested for restoration of wild-type phenotypes for
traits identified in Aim 1. These TLO reintroduction strains will also be used to identify paralog-specific bound
DNA targets by chromatin immunoprecipitation sequencing (ChIP-Seq) and affected regulons via RNA
sequencing (RNA-Seq). This work will determine the role of the TLO gene family and individual paralogs in the
parasexual cycle of C. albicans. Furthermore, it will begin to determine the extent of functional diversification
among members of a large paralogous gene family, which is largely untested beyond gene duplicates, and
provide greater understanding into how genes may be retained in tightly packed evolutionary spaces.

Public health relevance
PROJECT NARRATIVE The subtelomeres of eukaryotes commonly host gene families that have undergone lineage-specific expansions and contribute to adaptation of the organism, and in the common commensal and opportunistic fungal pathogen Candida albicans the telomere-associated (TLO) gene family is found across 13 of 16 chromosome ends. This proposal will investigate how C. albicans white-opaque switching and downstream mating programs are regulated by collective and individual TLO family members that encode MED2 homologs as part of the Tail module of the transcriptional regulatory complex Mediator, which is linked to phenotypic switching. Importantly, C. albicans phenotypic switching is linked to differences in virulence, providing compelling impetus for understand the genetic regulation of this transition.